Cancer Research Training and Education Coordination (CRTEC)

ABSTRACT: CANCER RESEARCH TRAINING AND EDUCATION COORDINATION
The overall goal of the Sidney Kimmel Cancer Center (SKCC) Cancer Research Training and Education
Coordination (CRTEC) Office is to create an integrated and innovative pipeline of activities to inspire and develop
the next generation of cancer researchers and provide diverse workforce career training and mentorship across
the research spectrum. Our commitment to excellence in training and education is central to the SKCC scientific
mission, and directly aligned with our goal to serve as a leading NCI-designated Comprehensive Cancer Center
in a highly diverse region that has persistently high cancer burdens. SKCC believes that investment of effort and
resources into our trainees perpetuates a virtuous cycle wherein the research and clinical missions of our Cancer
Center benefit proportionally to the growth and productivity of our trainees. Trainees are authors on >85% of
SKCC publications and are essential to research in laboratories and population science research teams. They
assist in the implementation of clinical trials, engage in community outreach, and are active citizens in our
communities of learning. The Associate Director (AD) for Training and Education, Felix Kim, PhD, leads CRTEC
activities with the support of SKCC-funded education coordinators. Innovative programmatic activities are offered
to high school and undergraduate students, pre- and post-doctoral trainees, researchers, clinicians, and staff.
Commensurate with expectations from an NCI-designated Comprehensive Cancer Center and in alignment with
our cancer research career enhancement principles, SKCC has developed and incorporated mechanisms at
multiple levels to assist early-career investigators with career development, including four T32 training grants.
Development of a robust cancer research career development training pipeline, mentored development of junior
faculty, and ongoing education and training of cancer researchers across the research spectrum is a fundamental
goal of SKCC and our consortium partners. In addition to the development of innovative and impactful new
training and educational initiatives, CRTEC coordinates existing training and career development activities at
Thomas Jefferson University and Drexel University, including in the preparation of grant applications at all levels.
The specific aims for the CRTEC include: (1) Develop additional platforms for innovative cancer-focused training
of pre- and post-doctoral fellows, clinical research fellows, and junior faculty. (2) Enhance mechanisms to
promote interdisciplinary training and develop core competencies in translational research. (3) Integrate cancer
disparities research training into the SKCC training environment. (4) Integrate CRTEC activities with community
outreach and engagement (COE). Significant strides toward these aims have been achieved in this project
period, and plans for further enhancing innovative approaches to interdisciplinary training, community outreach
and engagement, and integration of cancer health disparities research into SKCC training intitiaives will continue
to be a major focus of the next project period.